Impact of the 340B Drug Pricing Program on Medication Utilization, Health Outcomes, and Disparities in Medicare

PROJECT SUMMARY
Inadequate medication access and adherence causes poor health in the aging Medicare population—issues
which are particularly salient among disadvantaged populations.
The 340B Drug Pricing Program is an expansive, federal safety net program that intends to improve
medication access and health outcomes for disadvantaged patients. It entitles qualifying hospitals or clinics to
large manufacturer discounts when they purchase and dispense infused, injected, or oral outpatient drugs. The
intent is for 340B hospitals to use savings to increase drug access and invest in services to improve outcomes
for disadvantaged patients; however, there are no direct incentives nor oversight criteria to ensure this occurs,
and facilities are permitted to dispense 340B drugs to patients regardless of individual social or financial need.
Moreover, the 340B Program’s financial structure incentivizes prescription of higher volumes and more
expensive drugs. While this could result in improved guideline-concordant medication utilization and health
outcomes, it could also lead to dispensing potentially inappropriate medications or higher priced drugs.
Although most 340B hospitals report using Program savings for the intended purposes, there is limited
objective evidence to substantiate these claims. Whereas prior 340B research focused on Part B (physician
administered) drugs, recent changes make it critical to understand its impact on Part D (pharmacy dispensed)
drugs. Recent FDA approvals of expensive Part D specialty drugs has resulted in Part D drugs becoming
lucrative for 340B hospitals. 340B channels for dispensing Part D drugs have also multiplied. Hospitals could
originally dispense 340B drugs through (and share savings with) one contracted pharmacy. This restriction was
removed after 2010. Now, 340B hospitals may contract with an unlimited number of community pharmacies.
This study will link multiple datasets with a 100% sample of Medicare Part D enrollees, and use quasi-
experimental analytical methods to evaluate the: 1) impacts of 340B Program growth on volumes and
characteristics of Medicare Part D medications overall and among disadvantaged subgroups; 2) impacts of
340B Program eligibility on guideline-concordant Medicare Part D medication initiation, adherence, and health
outcomes for 8 diseases, overall and by disadvantaged subpopulation; and 3) whether specific hospital-level
characteristics are associated with positive impacts of 340B Program eligibility on guideline-directed medication
use, adherence, and clinical outcomes in Medicare. This project aligns with NIA’s emphasis on health care
disparities and patient adherence to treatment to promote health. Amidst competing legislative proposals to
either reform the 340B Program or protect the status quo, this study will provide large-scale objective evidence
on both intended and unintended consequences for Part D medication use and health outcomes to inform and
guide 340B Program policy reform decisions and advance health equity.

Public health relevance
PROJECT NARRATIVE The 340B Drug Pricing Program is an expansive federal safety net program intended to improve guideline- concordant medication utilization and health outcomes among disadvantaged populations, but the Program’s growth and concerns about unintended consequences have led to calls for more evidence on its health impacts among the overall population, and among disadvantaged subgroups, as well as possible reform. This proposed study will use quasi-experimental methods and claims data for a 100% sample of Medicare Part D enrollees to study 1) the impact of the Program’s growth on the volume, spending, and characteristics of medications dispensed for Medicare Part D enrollees overall and disadvantaged subgroups, 2) the impacts of hospital-level 340B Program eligibility on guideline-directed medication use, adherence, outcomes, and disparities for Medicare enrollees with 8 conditions (Alzheimer’s disease, atrial fibrillation, chronic myeloid leukemia, coronary artery disease, diabetes mellitus, hepatitis C virus, heart failure, and rheumatoid arthritis), and 3) hospital-level characteristics associated with positive impacts of 340B Program eligibility on guideline- directed medication use, adherence, outcomes, and disparities in these measures for Medicare enrollees with these conditions. Findings from this work will provide evidence to guide policymakers on how to reform the 340B Drug Pricing Program to best meet the Program’s goals and benefit disadvantaged populations.